Multifaceted interactions between lentiviral Vif and host molecules for viral infectivity enhancement

PROJECT DESCRIPTION
The APOBEC3 (A3) family of proteins are cellular cytidine deaminases that suppress human
immunodeficiency virus type 1 (HIV-1) infection by hypermutation of viral reverse transcripts and physically
blocking reverse transcription. To evade this host defense mechanism, HIV-1 expresses the virion infectivity
factor (Vif), which hijacks a cellular E3 ubiquitin ligase complex and targets A3 proteins (A3F/G/H/D) for
proteasome-mediated degradation. Besides degrading A3s, HIV-1 Vif also causes G2 cell cycle arrest by
targeting multiple protein phosphatase 2A (PP2A) regulators (PPP2R5 proteins) for degradation. Adding to the
complexity of Vif-host protein interactions, HIV-1 Vif utilizes the transcription factor CBFβ as a non-canonical
cofactor, while maedi-visna virus (MVV) Vif co-opts the prolyl isomerase cyclophilin A (CypA) instead. Our goal
is to establish the biochemical and structural principles for the multifaceted activities of lentiviral Vif molecules
that recruit cellular factors to degrade host proteins via ubiquitin-proteasome pathways. To achieve our goal,
we will use a combination of biochemical, biophysical, structural biology, and cellular functional techniques. To
establish the mechanisms by which A3 proteins are targeted by the HIV-1 Vif (Aim1), we will determine high-
resolution structures of the A3-Vif-E3 interaction complexes, validate these structures by structure-guided
mutagenesis experiments in vitro and in vivo, and interrogate the molecular determinants of Vif/A3/E3 ligase
assembly and activation. In addition, we will also study the degradation-independent mode of Vif inhibition of
A3 deamination and antiviral activities. To better understand CypA-mediated formation of MVV Vif-E3 ubiquitin
ligase (Aim2), we will assemble MVV Vif/CypA/E3 ligase complexes with or without A3 substrates, determine
their high-resolution structures, and perform biochemical and functional validations of our structural
observations. The influences of capsid proteins on the assembly and activation of MVV Vif-E3 ligase will also
be investigated. To delineate the mechanisms of PPP2R5/PP2A recruitment by lentiviral Vif-E3 ubiquitin
ligases (Aim3), we will investigate the effects of PPP2R5 proteins on the assemblies of the CBFβ-mediated
HIV-1 Vif and CypA-mediated MVV Vif-E3 ligases, obtain high-resolution structures, and perform structure-
guided validations. Our comprehensive research design provides a robust approach that will generate
unprecedented insights into the diverse functions of lentiviral Vif molecules.

Public health relevance
Project Narrative The proposed work aims to elucidate the diverse set of activities employed by a class of viral proteins when degrading cellular factors to subvert the host’s immune defenses and enhance viral infectivity. The information obtained from this work will facilitate the design of new antiviral inhibitors for use in therapeutic control of HIV and other virus infections.